Core C - Integrated Quantitative Science (IQS)

CORE C: ABSTRACT
The mission of the Integrated Quantitative Science (IQS) Core is to provide state-of-the-art data management,
study design, and statistical analysis support for the UNC Pancreatic Cancer SPORE translational research
projects. This centralized core will provide the technical skills for the statistical analysis of clinical, translational,
and multi-platform genomic data from individual research projects to provide a broad clinical and molecular
portrait of pancreatic cancer. Results from each project will inform the design and analysis of a future SMART
trial, which will involve state-of-the-art clinical trial design and machine learning methods to determine the best
sequence of treatments, tailored to individual patient-level characteristics. Complementary skills possessed by
the Core faculty will also lead to the application and development of (as needed) cutting-edge approaches for
cross-platform data integration and high-dimensional biomarker discovery to facilitate patient subtyping and
optimize clinical decision-making. This Core will provide appropriate input into design, management, and
analysis to ensure that SPORE investigators pursue the most promising lines of translational research.

Public health relevance
CORE C: PROJECT NARRATIVE The Integrated Quantitative Sciences Core participates in the design of all clinical trials, animal studies, and translational research proposed in the SPORE to ensure that all relevant studies are well powered, utilize appropriate statistical methods, and are properly designed to address relevant hypotheses of study aims. In this manner the Core supports the rigor and reproducibility of all results that are generated by the SPORE, which in turn has significant impacts in the fields of public health and medicine. Expert analysis of project data and clear reporting of scientific results are of similar importance for addressing scientific hypotheses and similarly have strong implications in public health.